Inflammatory stressors in serotonergic brainstem dysfunction and SIDS

Project Summary
Sudden infant death syndrome (SIDS) remains the leading cause of post-neonatal mortality in the U.S.– an
unchanging and devastating fact despite implementation of safe sleep practices (extrinsic risk reduction).
Addressing this 21st century health crisis now requires discovery of intrinsic biological vulnerabilities and
plausible molecular pathways that might lead to biomarkers and preventative interventions. In multiple
independent SIDS tissue datasets, serotonergic (5-HTergic) abnormalities in the brainstem were consistently
identified; in animal models of reduced brainstem 5-HTergic activity, compromised autoresuscitation (AR) was
observed – the ability of mouse pups to recover from cycles of asphyxial apneas and bradycardia (resembling
the cycles of apnea and bradycardia observed in some SIDS cases) was significantly diminished. Such 5-
HTergic system dysfunction, as an intrinsic vulnerability, may be caused or exacerbated by extrinsic stressors
such as pre- and/or postnatal hypoxia (e.g., placental insufficiency, parental smoking) and/or antemortem
infections. Hypoxia and infection are each risk factors for SIDS and can increase neuroinflammation, which can
impair AR. Notable new findings in some SIDS cases as compared to controls are elevations of the
neuroinflammatory markers IL-1β, IL-2, IL-4, IL-17, and GM-CSF and/or in neopterin (a marker of Th1
(proinflammatory) cellular activation) in the cerebrospinal fluid. We postulate that neuroinflammation,
triggered by hypoxia and/or antemortem infections (bacterial or viral), interact to create a vulnerable 5-
HTergic system, reduce AR effectiveness, and increase the risk for sudden death, and may underlie
some SIDS cases. We propose: 1) To quantitate inflammatory mediators within SIDS brains and determine
whether a profile of mediators associates with 5-HTergic brainstem abnormalities. We will test the hypothesis
that specific inflammatory profiles associate with low 5-HT1A and 5-HT2A receptor binding and low 5-HT levels. 2)
To map at single-cell resolution, differences in gene expression profiles and overall cell-type composition/states
of brainstem tissue across SIDS cases (the SIDS subsets identified through Aim 1) and controls. We hypothesize
that SIDS subsets will be distinguished by specific inflammatory profiles in glia, neurons, and/or endothelial cells,
and gene expression differences will identify novel, previously unrecognized SIDS-related pathways for
mechanistic testing in cell and animal models. 3) Assess the interaction between chronic intermittent hypoxia
(gestational to P8) and postnatal antemortem infection on molecular, cellular, inflammatory, and physiological
readouts, including the autoresuscitation response (AR). We will test the hypothesis that the combined effects
of antemortem hypoxia and infection interact to create greater neuroinflammation, more severe 5-HTergic
deficits, and increased likelihood of AR failure, compared to either hypoxia or infection alone. SIDS research
must address the missing mechanistic links between risk factors and postmortem pathology to develop life-
saving interventions.

Public health relevance
Project Narrative The Sudden Infant Death Syndrome (SIDS) is a major cause of death in the first year of life for which there is no known cause. While our research strongly implicates defects in and reduced function of the life-sustaining brainstem serotonin system in a major subset of SIDS cases, the mechanisms underlying these defects remain unknown. We will test the hypothesis, directly in SIDS tissue as well as mechanistic validation in model systems, that neuroinflammation in the brain, originating from environmental factors (low oxygen or infections), causes or exacerbates the consequences of abnormalities within the serotonergic system and reduces the likelihood of successful recovery from reflex apneas (periods of breathing cessation). Confirmation of our hypothesis would guide new therapeutic strategies targeting neuroinflammation and aimed at prevention in a substantial group of SIDS infants.